Texas A&M Center for Environmental Health Research (TiCER)

ABSTRACT
The primary objective of the Translational Research Support Core (TRSC) is to promote research translation
and accelerate basic, applied, and community-focused studies to support the overall goal of the Texas A&M
Center for Environmental Health Research to “advance innovative solutions for addressing exposure-stressor
interactions in underserved populations in urban and urbanizing areas in the state of Texas”. This Core builds
from the prior success of the Integrated Health Science Facility Core that enabled innovative translational
research across three domains: (1) human community-focused studies; (2) animal models of human disease;
and (3) novel alternative toxicology models through competitive $10,000 use vouchers to support diverse
translational studies. Rigor, transparency and accountability of this operational model, that distributed over
$310,000 in vouchers in the first 4 years of the Center, allowed for realization of tangible and substantial scholarly
impact through publications and new awards from NIEHS, EPA and other sources exceeding $7,000,000. To
further enhance member access to facilities and resources that stimulate translational science, the TRSC will
lead activities accelerating investigator-driven, translationally focused studies across three updated workspaces:
(1) molecular phenotyping (-omics and imaging), (2) experimental models (animal and cell-based new approach
methods), and (3) exposomics (both targeted and untargeted analytical approaches). This approach aligns with
the Center’s community and mechanistic themes to bolster translation across the NIEHS research framework.
Accordingly, the TRSC will administer $15,000 vouchers for use across the three workspaces through quarterly
solicitations. The molecular phenotyping workspace provides members priority access, training and support for
diverse imaging technologies and -omics tools, from whole genome, to targeted high-throughput and single cell.
The experimental models workspace offers members services and support for creating and characterizing new
models, including in vitro (human and mouse organoids, iPSCs, and tissue chips) and in vivo (population-wide
mouse and transgenic/knockout models) coupled with easy access to exposure (i.e., inhalation chambers) and
response resources (i.e., physiological phenotyping). The exposomics workspace provides members efficient
access to state-of-the-art analytical instrumentation and methodologies for experimental- and field-based
applications. Overall, the TRSC will promote interdisciplinary collaborations, a hallmark of translational, by
prioritizing high impact vouchers (i.e. collaborative team science) and delivering expert advice on experimental
design and research compliance. The TRSC will work closely with the other Center Cores to maximize research
translation, especially as it pertains to under-resourced communities in the urban and urbanizing areas across
the state (the Texas Triangle). Cores will integrate curriculum with a focus on the policymaking process and
communicating research to achieve actionable outcomes at changing exposures and improving public health.